Sustained delivery of therapeutics to the visual system using genetically modified autologous mesenchymal stem cells to treat blinding diseases

PROJECT SUMMARY
The objective of the proposed research is to evaluate the safety and efficacy of a novel method of delivering
therapeutics to the central nervous system (CNS) and the retina to treat diseases associated with visual
impairment. The hypothesis tested will be that autologous genetically modified mesenchymal stem cells
(MSCs) can serve as effective vehicles for sustained delivery of therapeutics to visual centers in the brain and
to the retina for the treatment of blinding diseases that result from pathology in one or more parts of the visual
system. Proof of concept studies will be performed using a well-characterized and validated canine model of
CLN2 neuronal ceroid lipofuscinosis, a disease with pediatric onset characterized by widespread
neurodegeneration resulting in progressive loss of vision due to degeneration of both the retina and visual
processing centers in the brain, cognitive and motor decline, and seizures. CLN2 disease is caused by
mutations in TPP1, which result in deficiencies of the soluble lysosomal enzyme tripeptidyl peptidase-1 (TPP1).
It is hypothesized that providing TPP1 to the CNS using implantation of autologous MSCs that have been
genetically modified to produce and secrete the protein will ameliorate disease-related vision loss in the canine
model. To test this hypothesis, TPP1-producing MSCs will be injected into the vitreous of the eye and into the
cerebrospinal fluid (CSF) of dogs affected by CLN2 disease. Based on previous studies, significant transfer of
TPP1 from cells implanted in these locations to the retina and brain are anticipated, respectively. Functional
vision will be evaluated in treated dogs using a novel iPad tablet based test that requires a choice between a
screen displaying solid grey and a screen displaying a black and white stripe / grating pattern. Retinal function
will be assessed with electroretinography, and retina-CNS interactions will be assessed with quantitative
pupillometry. Dogs will also be monitored with established biomarkers of disease progression to determine if
implantation of TPP1-producing MSCs results in amelioration of the neurological disease signs not directly
associated with vision, preserves cognitive function, inhibits brain atrophy, and extends healthy lifespan when
compared with control dogs. In addition, assessed will be the safety, persistence, and distribution of the
implanted MSCs and the TPP1 enzyme they produce through histopathologic and immunohistochemical
analysis of CNS tissues. Successful accomplishment of these aims will set the groundwork for testing this
approach to therapy in children suffering from CLN2 disease and similar lysosomal storage disorders. It will
also serve as the prototype for adopting this approach to treat many other diseases affecting the CNS and
retina.

Public health relevance
PROJECT NARRATIVE Visual impairment associated with central nervous system (CNS) degeneration and/or retinal degeneration could be ameliorated by long-term, sustained delivery of a therapeutic protein to the affected regions of the visual system. The proposed research will test whether implantation of autologous, bone-marrow derived mesenchymal stem cells that have been genetically modified can be used to deliver a therapeutic protein to the retina and to central visual pathways in the brain to prevent vision loss in a canine model that exhibits progressive degeneration of the retina and the central nervous system. If effective in the dog model, this approach can be adapted for use in people with diseases characterized by degeneration of the visual system.